Comparative analysis of the 4D encoding of regulatory networks in stem cells

DESCRIPTION (provided by applicant): While all of the cells in a human body share the same genome, different cell types have characteristic gene expression patterns that are controlled by elaborate gene regulatory networks. Understanding the encoding of these developmental programs in the genome and how they give rise to the diverse transcriptomes of differentiated cell types is the primary goal of functional genomics and one of the driving research themes of modern biomedical research in general. There is now ample evidence that the tight spatio-temporal regulation of the expression of thousands of genes is controlled by regulatory elements called enhancers that can be found far away from their cognate promoters via long-range looping interactions. With the development a multiple high-throughput assays to determine protein-DNA interactions, gene expression levels, and long- range interactions, we are on the cusp of sophisticated integrative studies where we can use combinations of these assays to ask fundamental questions about how protein-DNA interactions and enhancer-promoter interactions genome-wide account for changes in cell state across high-resolution differentiation time courses. We propose to develop several new experimental and computational methods to increase the resolution, applicability, and validation of protein-DNA interactions as well as long-range interactions to understand their role in controlling gene expression during differentiation from progenitor cells to differentiated cell types. Once developed, these methods will be widely applicable across a variety of studies in functional genomics. To demonstrate the power of these methods, we will apply them to study the differentiation of existing human, mouse, horse and dog stem cells into cardiomyocytes and neurons in order to understand the role, conservation and dynamics of these long-range interactions. The results will greatly expand our understanding of both the evolution and role of long-range interactions in homologous cell differentiation in mammals and whether particular long-range interactions are critical for the efficient differentiation of stem cells into fully- differentiated cell types.

Public health relevance
Comparative analysis of the 4D encoding of regulatory networks in stem cells. Ali Mortazavi UC Irvine Science Area Designation: 8 High Throughput and Integrative Biology Project Narrative / Public Health Relevance Statement: The control of gene expression is tightly regulated during normal development and is typically misregulated in a spectrum of diseases such as cancer. Regulatory elements that control the specificity of gene expression are typically encoded by "enhancers" that can be a great distance from their target genes and that work by long-range looping interactions. We will develop novel methods to map, validate, and analyze these long-range interactions and apply them to high-resolutions, comparative studies of mammalian embryonic stem cell differentiation into cardiomyocytes and neurons to understand the scope and conservation of these long-range interactions and their critical role in developing fully functional differentiated cells for regenerative medicine.